Molecular basis of mitochondrial calcium extrusion - a key target in ischemic heart disease

PROJECT SUMMARY/ABSTRACT
Ischemic heart disease remains the leading cause of death in the United States. Treating its associated
pathologies is complicated by ischemia-reperfusion (I/R) injury, which further damages affected tissue due, in
part, to mishandling of mitochondrial Ca2+. While physiological mitochondrial Ca2+ is an important component of
cellular metabolism and signaling, aberrant Ca2+ accumulation during I/R injury is a key contributor to apoptotic
and necrotic cell death. Targeting the molecular agents mediating mitochondrial Ca2+ extrusion thus poses a
promising therapeutic avenue against I/R injury. However, the underlying agents and mechanisms facilitating
mitochondrial Ca2+ extrusion remain poorly characterized. Here, TMEM65 is an emerging target implicated in the
process of mitochondrial sodium-dependent calcium extrusion (mNCX) as its overexpression was recently
reported to enhance cellular mNCX activity. However, the molecular basis of this important function remains to
be elucidated. The proposed project will investigate the molecular mechanisms bridging TMEM65 to mNCX. The
Research Training Plan proposes an innovative, multidisciplinary approach incorporating reductive biochemistry
(Aim 1), structural studies (Aim 2.1), and cell biology (Aim 2.2) to investigate the role of TMEM65 in Na+-coupled
Ca2+ transport and its relevance to cellular Ca2+ signaling. In Aim 1, the Applicant will functionally interrogate and
quantitatively analyze the activity of purified TMEM65 molecules in a chemically defined, liposomal environment
to unambiguously characterize the function of TMEM65. In Aim 2, the Applicant will determine the molecular-
basis for TMEM65 function and modulation at the atomic level via cryogenic electron microscopic studies and
perform structure-function analyses. Completion of the proposed aims will yield critical insights on mitochondrial
Ca2+ signaling and cellular energetics. The Applicant has suitable prior training in protein biochemistry and strong
preliminary data to support the feasibility of his proposed work. Additionally, the Applicant will receive further
training in membrane protein biochemistry, functional assays, and structural analysis as well as career
development skills in scientific communication, project management, and mentorship. The Project Sponsor and
surrounding Training Environment are well-suited to provide the guidance and resources necessary for
completing the proposed scientific and training aims, which will additionally prepare the Applicant for a career as
an independent research scientist. Ultimately, the research proposed here will improve our understanding of
cellular physiology and, by furthering our understanding of mitochondrial Ca2+ extrusion, effectively provide a
new avenue for the development of therapeutics against I/R injury.

Public health relevance
PROJECT NARRATIVE Mitochondria have multiple protein-driven pathways to uptake and release calcium ions, which helps regulate overall cellular calcium levels and functions as an important signal for tuning cell function. These pathways are disrupted during heart disease, contributing to injury at the cellular level, but the mechanisms underlying these pathways are poorly understood. This study investigates novel protein agents of the cell responsible for releasing mitochondrial calcium in response to sodium, which will improve our mechanistic understanding of these pathways and help guide the development of new drugs and therapeutics.